Development of an alias-free color flow imaging technique using Doppler tolerant coding for improved diagnostic ultrasound

PROJECT SUMMARY
Color Flow Imaging (CFI) is a ubiquitous mode on ultrasound scanners and has been around for several
decades. Several limitations still exist for CFI: 1) the highest velocity that can be estimated depends on the pulse
repetition frequency (PRF) of the imaging system, i.e., the Nyquist frequency, and high flow velocities lead to
aliasing of the estimates, 2) for deeper structures, the PRF must be reduced, which makes aliasing artifacts even
worse for fast flow, 3) in many scanners, the PRF depends on the size of the color flow map, and so for fast
moving flows, e.g., the heart, smaller CFI windows are needed to maintain a higher PRF, 4) the signal-to-noise
ratio (SNR) in deeper structures can be low, resulting in poorer results, and 5) tissue motion can also reduce the
clarity of CFI as the flow signal can sometimes be difficult to separate from tissue signal. Clutter filters attempt
to remove the tissue signal, but for fast moving tissues, like the heart, the task is difficult. Even with these
limitations, CFI is an invaluable tool for diagnostic ultrasound. However, alleviating these limitations would result
in better diagnostic outcomes and open the door for additional applications of this technology.
The basic approach to CFI has not changed over the last few decades. In this research, we are proposing a
highly innovative and fundamentally new approach for CFI that does not face the same limitations as traditional
methods. To achieve this, we propose the use of Doppler-tolerant codes for estimating flow parameters.
Specifically, we will use up and down hyperbolic chirps to estimate flow parameters from ultrasound echoes. We
call this approach ‘chirpCFI’. Hyperbolic chirps have a unique property that scattering of the chirp from moving
objects, e.g., a red blood cell, results in a time shift of the compressed waveform. The faster the object is moving,
the more the compressed chirp is shifted in time. The time shift of the compressed up chirp will be in the opposite
direction of the time shift of the compressed down chirp. By comparing the shifts in the compressed up and down
chirps, the flow speed and direction for a scatterer can be estimated. As a result of the unique nature of the
hyperbolic chirps, flow can be estimated without the worry of aliasing because the flow estimates do not depend
on the PRF. The SNR is improved because the energy in the chirp is higher. Deeper structures can be imaged
because the approach does not depend on PRF and the SNR is higher. Tissue clutter signal is reduced because
the flow signal does not depend on multiple moving frames to provide an estimate.
In this proposal, we will further optimize and validate chirpCFI in phantoms and in vivo, under challenging
scenarios such as imaging the heart in motion. To successfully meet the goals of research, two specific aims
are proposed. The first aim is to further optimize the hyperbolic chirp-based chirpCFI approach to provide the
best image quality. The second aim is to validate and quantify image quality of chirpCFI in vivo with applications
in the heart. The scientific premise of the research is that a novel flow technique can be engineered, based on
using up and down hyperbolic chirps, that overcomes current limitations of long held methods for CFI.

Public health relevance
PROJECT NARRATIVE While color flow imaging (CFI) is ubiquitous on ultrasound scanners, the fundamental approach to CFI has not changed in several decades. In this research, we are proposing a novel shift in the paradigm of how CFI is performed, by using Doppler tolerant codes to provide estimates of flow; we call the technique chirpCFI. The new technique will eliminate aliasing artifacts, reduce sensitivity to tissue motion, improve signal-to-noise ratio and depth penetration, and increase the range of flow speeds that can be imaged.